Supplemental Request: Therapeutic APOE2 overexpression for early Alzheimer's disease

Alzheimer's disease (AD) is the most common neurodegenerative disease, characterized by the
gradual appearance of progressive cognitive dysfunction with neuronal death in multiple areas
of the cerebral cortex. Current therapies are symptomatic and there are no available treatments
that alter the natural history of the disease. In previous proof-of-concept studies, and backed by
strong human genetics data, we demonstrated that a single injection of an adeno-associated
viral (AAV) vector into the lateral ventricle of AD mice leads to sustained APOE2 expression
from ependymal cells and secretion into the cerebrospinal fluid (CSF). Once in the CSF, this
protein distributes throughout the entire brain with a beneficial effect on many AD-related
phenotypes. Moreover, therapeutic levels of expression were also achieved using the same
approach in non-human primates.
Here, we propose to move our therapeutic vector through a milestone-driven process that ends
with an IND application for a Phase 1 clinical trial in human subjects. Specifically, we propose to
1) hold a Pre-IND Type B meeting with the CBER of the FDA to receive input on the design of
the planned GLP tox study and the proposed Phase 1 protocol; 2) produce GMP-process
comparable vector (GLP vector); 3) perform IND-enabling GLP pharm/tox studies in nonhuman
primates (Rhesus macaques); 4) generate GMP-grade vector; and 5) prepare and file the IND
with the FDA for a phase I/II clinical trial in subjects with early symptomatic AD.

Public health relevance
Alzheimer's disease (AD) is the most common neurodegenerative disease, a fatal condition that affects cognition, with no available disease-modifying therapies. We have developed vectors that correct disease readouts when delivered to mouse models of the disease, through a delivery approach that we show also works in nonhuman primates. In this milestone-driven application, we will move from IND enabling toxicology studies to an IND application for a phase 1 safety trial.